Development of innovative genetically encoded tools to dissect melanocortin-4 receptor signaling in neuronal circuits

PROJECT SUMMARY/ABSTRACT
The absence of genetically encoded tools capable of activating endogenous melanocortin-4 receptor (MC4R) in
the brain with cell selectivity and temporal control has created a critical gap in the ability to study the neural
circuits regulating feeding behavior and energy homeostasis. The long-term goal of this project is to map the
melanocortin system microcircuitry by activating MC4R in specific neuronal populations to study effects on
feeding behavior and physiology. Pharmacological methods lack cell-type specificity and spatial resolution, while
existing chemogenetic and optogenetic techniques do not replicate natural MC4R signaling events. The overall
objective of this application is to engineer genetically encoded tools capable of achieving high spatiotemporal
control over MC4R activation. The rationale for this project is that surface-tethered protein switches can be
employed to control the activity of the MC4R agonist alpha-melanocyte stimulating hormone (Į-MSH). Specific
Aim 1 will engineer a chemogenetic controlled Į-MSH (ccMSH) for drug-dependent activation of MC4R using
chemically activated protein domains (CAPs) to cage Į-MSH. The ccMSH will be optimized for high drug
dependence and assessed in mammalian cell cultures to validate the system's functionality. It will then be applied
to mouse models to observe behavioral and physiological responses to chemical-dependent MC4R activation.
Specific Aim 2 will develop optogenetically controlled Į-MSH (ocMSH) for light-dependent activation of MC4R
using the light-oxygen-voltage sensing (LOV) domain to cage Į-MSH. Directed evolution will be used to improve
the membrane trafficking and photoactivation of the LOV domain. The effectiveness of ocMSH will be
characterized in cell cultures and tested in mouse models to assess the impact of light-gated MC4R activation
on behavior and physiology. Upon successful completion, this project will introduce innovative and novel
chemogenetic and optogenetic tools that will enable detailed studies of the melanocortin system in vivo, providing
high spatiotemporal resolution of endogenous MC4R activation. The anticipated outcomes will significantly
impact our understanding of the regulation of energy homeostasis and feeding behavior, contributing significantly
to the development of therapeutic strategies for treating obesity and related metabolic disorders.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it aims to provide critical insights into the regulation of energy homeostasis and feeding behavior by developing novel chemogenetic and optogenetic tools for precise activation of endogenous MC4R. The project is relevant to the NIDDK's mission because it will facilitate advancements in understanding the melanocortin system, thereby informing the development of targeted therapeutic strategies for treating obesity and related metabolic disorders.